Manufacturing and Formulation Process Development for a Prophylactic Cholera Phage Cocktail

PROJECT SUMMARY
The World Health Organization (WHO) estimates that approximately 1.3 billion people globally are at risk for
cholera, a severe diarrheal disease caused by the bacterium Vibrio cholerae that is spread through contaminated
water sources and substantial secondary person-to-person transmission. In January 2023, the WHO classified
the global resurgence of cholera as a grade 3 emergency, its highest internal level. More than 708,200 cases
were reported in 30 countries across five WHO regions in 2023, a 50% increase from 2022. The country’s case
fatality rates have far surpassed the threshold of <1%, reaching 23.8% in the Congo. The sustained upsurge is
evident in 2024, disrupting the 2030 disease elimination goals of the WHO Global Taskforce for Cholera Control
(GTFCC). Current prevention methods, such as the oral cholera vaccine (OCV) and water, sanitation, and
hygiene (WASH) campaigns, require significant investment of resources and time for efficacy, but household
contacts of cholera patients often present with cholera symptoms two to three days after the initial patient
becomes sick. In addition, the preventive use of antibiotics is not recommended due to widespread resistance
for cholera and other pathogens in the same environment. There is a pressing need to develop a targeted clinical
intervention to prevent the community spread of cholera using a fast-acting prophylactic treatment. PhagePro
aims to fill this gap with its product ProphaLytic-VcTM (PVC). PVC is an orally administered bacteriophage (phage)
cocktail comprised of Vibriophages ICP1, ICP2, and ICP3.
In this Direct-to-Phase II SBIR proposal, we aim to partner with two Contract Development and Manufacturing
Organizations (CDMO), JAFRAL and Serán Bioscience, to scale up manufacturing and formulation of PVC and
establish specifications for future clinical trial material production as an orally administered, cold-chain
independent, solid dosage form, which are critical characteristics identified by Key Opinion Leaders for an
innovative cholera intervention. Stability of PVC in hot and humid environments will enable Ministries of Health
to stockpile PVC in-country and distribute to identified cholera hotspots quickly. This mechanism will increase
timeliness of the cholera outbreak response, which has been identified as the key factor in controlling an outbreak
in both endemic and non-endemic settings.
First, PhagePro will collaborate with JAFRAL to establish upstream and downstream manufacturing processes
of each PVC phage using 1 liter bioreactor batches based on previously established phage growth parameters.
JAFRAL will then perform scaled-up confirmation runs of ICP1, ICP2, and ICP3. At this stage, the individual
phages will be in liquid buffers (Drug Substance, DS). Second, PhagePro will collaborate with Serán to finalize
excipient formulation and develop a large-scale manufacturing process for enterically coated, encapsulated
spray-dried powder in blister packaging (Drug Product, DP). Third, PhagePro will in parallel collaborate with
JAFRAL to develop analytical methods for viability and purity, according to prior formal Type C Meeting
responses with the U.S. FDA, to optimize growth efficiency, phage viability during processing, and batch purity.
Additionally, PhagePro will collaborate with Serán to develop the potency method for PVC, which will be
transferred to JAFRAL. Lastly, JAFRAL and Serán will then qualify the developed analytical and potency
methods for DS and DP under GMP and establish specifications. Throughout the proposed studies, PhagePro
will be responsible for managing this project and act as the final decision maker.
At the successful conclusion of the Phase II grant, we will have established scaled-up manufacturing and
formulation processes as well as specifications for future clinical trial material production. Future investments
and non-dilutive funding will fund clinical surveillance studies, GMP manufacturing for clinical trials, and a first-
in-human trial to demonstrate proof-of-clinical-efficacy.

Public health relevance
PROJECT NARRATIVE This proposal aims to develop processes for the manufacturing and formulation of a phage-based clinical intervention, ProphaLytic-VcTM (PVC), to prevent the community spread of cholera. With the successful completion of preliminary studies, PhagePro has demonstrated that PVC is highly effective in preventing Vibrio cholerae colonization of the small intestine in mice and rabbits, thus protecting against cholera. We have established robust small-scale phage manufacturing parameters, optimized critical quality control assays, constructed an avirulent V. cholerae manufacturing strain, and completed Investigational New Drug (IND)- enabling studies aligned with the FDA’s expectations for phage products. With Serán Bioscience, we have optimized small-scale processes for solid dosage formulation of each PVC phage. With this Direct-to-Phase II SBIR proposal, we aim to establish scaled-up manufacturing and formulation schemes for PVC Drug Substance (aqueous solution) and Drug Product (solid dosage), which are enteric capsules with spray-dried PVC phages at 1010 plaque-forming units (PFU) total. We will also develop and qualify analytical and potency methods for DS and DP. The success of this study will position PhagePro to produce future Good Manufacturing Practice (GMP)- quality clinical trial material for its first-in-human Phase 1/2 clinical trial of PVC with our in-country partners, the International Centre for Diarrhoeal Diseases Research, Bangladesh (icddr,b) in Dhaka.